Long-Term Mobility and Well-being of New Orleans Residents after Hurricane Katrina

PROJECT SUMMARY
Weather-related disasters are a regular occurrence in the U.S., yet we know very little about their long-term
impacts. Hurricane Katrina, which struck New Orleans on August 29, 2005, is one of the most researched
disasters in U.S. history with most health-related research focused on short-term outcomes, such as mortality,
and mental health. In general, little is known about long-term effects of disasters in the U.S. due to a lack of
appropriate data and the high cost of designing and collecting representative samples of the exposed
population after a disaster. This highly innovative project overcomes barriers to scientific knowledge about
long-term disaster impacts by using existing census, survey, and administrative data to construct several
longitudinal population representative data sets for the Katrina-affected New Orleans population with sample
sizes large enough to study small groups and sample designs that will produce unbiased results. The
longitudinal datasets produced will allow for the examination of hypotheses based in stress and social
vulnerability theories. The analyses will examine the residential mobility, neighborhood characteristics,
economic status, mortality, and health outcomes of the Katrina-affected residents of New Orleans in the
decade following the disaster (2006-2015). The results will provide key information for designing effective
disaster mitigation and response policies to promote wellbeing and eliminate health disparities among disaster-
affected populations.

Public health relevance
PROJECT NARRATIVE The project investigates the effects of Hurricane Katrina, which struck on August 29, 2005, on the residential mobility, health and wellbeing of residents of New Orleans over the following decade. The innovative approach to constructing longitudinal, population-representative data of New Orleans residents allows for the measurement of disparities in mobility, health, and wellbeing without the biases inherent in most disaster research. The findings will provide policy relevant evidence for designing effective disaster recovery policies and identifying vulnerable population segments.